Community Engagement Core

MT INBRE's Community Engagement Core (CEC) has been critical to the program's success for the last 18
years. During MT INBRE III, the CEC helped develop two IDeA programs in Montana, The Center for
American Indian and Rural Health Equity (CAIRHE) and the American Indian/Alaska Native Clinical and
Translational Research Program (AI/AN CTRP). Both new programs have a CEC similar to MT INBRE's, and
we began to integrate these programs during this past year. Because the CEC also will be critical to MT
INBRE IV, we will strengthen it by continuing to integrate the CECs of the 3 IDeA programs, administering
them as a coordinated network. The integrated MT IDeA CEC will be stronger than the sum of its three parts
and will eliminate redundancy among the programs. Thus, the MT IDeA CEC will contribute more effectively to
accomplishing the overall MT INBRE goal of improving the health of Montana's rural and Native communities.
To achieve these goals, we will accomplish three specific aims. Aim 1: Continue to develop and organize the
new integrated MT IDeA Community Engagement Core. Aim 2: Recruit, train and mentor tribal and rural
health equity researchers. Aim 3: Enhance and develop Montana's capacity for health equity research.